Translating the Clinical Knowledge of Mendelian Diseases to Real-world EHR Data to Improve Identification of Undiagnosed Patients

PROJECT SUMMARY
The last two decades have seen extraordinary advances in the cost, accessibility, and interpretability of
genetic testing. In the context of this astonishing progress, it is striking that for many rare genetic diseases,
diagnostic delay – the time between onset of symptoms and a diagnosis – has not improved. Current health
care services are unable to effectively identify patients that would benefit most from genetic testing. As a result,
many patients affected by genetic disease are not diagnosed for years after symptoms develop, or are never
diagnosed at all, leading to costly diagnostic odysseys, health care disparities in genetic services, and
preventable morbidity and mortality for those with conditions that have an effective, targeted treatment.
Much of what we know about genetic disease is based on studies of individuals and their families. This
has proven to be a powerful method for discerning the clinical characteristics of genetic disease, generating
one of the most enduring and useful resources in medical genetics: the online Mendelian inheritance in man
(OMIM). However, clinical descriptions in OMIM do not always match the way diseases are described in real-
world EHR data. To improve our ability to use genetic testing effectively, we can learn, at scale, from the data
clinically captured while testing and diagnosing patients. EHRs provides an opportunity to study genetic
disease from a new perspective, enabling scalable methods that augment existing the knowledge base to
include phenotypes observed in real-world health care data.
This proposal builds on our prior work curating genetic testing data from the EHR and developing tools
to identify undiagnosed patients from characteristic genetic disease profiles. Specifically, we have built a
database of clinical genetic testing information extracted from the EHR for over 20,000 individuals, with
detailed information regarding test results, variant interpretation, and diagnosis. From this resource, we can
define EHR-based cases series of individuals with genetically-confirmed clinical diagnoses of genetic disease.
We will use a data-driven approach to discern characteristic phenotypes from the EHR-based case series, and
merge these results with clinical descriptions from OMIM. This approach seeks to translate the curated,
durable knowledge cataloged in OMIM to a portable and scalable product that can layered on any set of EHRs
to identify undiagnosed patients with genetic disease.
The ultimate goals of this proposal are leverage these data and tools to 1) translate and add to clinical
curations of genetic diseases using real world EHR data, 2) assess diagnostic yield of EHR-based tools that
identify undiagnosed patients and 3) characterize the contribution of demographic and phenotypic features that
lead to earlier or later diagnosis.

Public health relevance
PROJECT NARRATIVE Hundreds of millions of individuals suffer from rare genetic diseases and despite improvements in genetic testing technology and awareness many suffer years of diagnostic odyssey before getting a diagnosis if they get one at all. Increased use of electronic health records (EHR) have provided an opportunity to translate the current knowledge of genetics diseases into real world clinical care to add to the understanding of disease presentation and build tools to identify undiagnosed patients. Here, we leverage a previously curated EHR- based database of genetic testing and diagnosis and both knowledge-driven and data driven tools to identify undiagnosed patients to 1) provide a resource translating and extending current clinical descriptions of genetic diseases to the EHR, 2) assess the diagnostic yield from EHR tools to identify undiagnosed patients and 3) improve our understanding of socioeconomic, demographic, and phenotypic factors that contribute to diagnostic delay.